Evaluating Microaggressions among Latinx Individuals with Obesity

PROJECT SUMMARY/ABSTRACT
Despite being one of the largest and fastest-growing demographics in the United States, Latinx persons
experience striking health disparities, particularly in terms of obesity. One possible reason for this disparity
among Latinx persons is that this population is disproportionately affected by stressful life conditions, including
discrimination, which may lead to higher rates of obesity-related clinical correlates (e.g., emotional eating,
physical inactivity). Subtle discrimination related to ethnic status at the daily level, known as ethnic
microaggressions (MAs), is common among Latinx persons, and may be an underrecognized factor that
accounts for significant and unique variance in obesity-related eating and physical inactivity behaviors. The
goal of this R21 project is to elucidate the concurrent and temporal role of ethnic MAs in obesity-related eating
and physical inactivity behaviors among Latinx persons using time sampling methodology (over the course of
28 days). Participants (N = 150; 50% female) will be Latinx adults meeting criteria for obesity. Furthermore, the
present proposal will determine whether anxiety sensitivity (fear of somatic sensations such as shortness of
breath, racing heart, and chest pain) accounts for the relation between ethnic MAs and obesity-related eating
behaviors (i.e., greater emotional eating, food cravings, loss of control while eating, and episodes of
overeating) and physical inactivity behaviors (i.e., greater fears of exercise and perceived barriers to engage in
physical activity [PA] and lower exercise self-efficacy and moderate-to-vigorous PA), and test theoretically
driven risk and resilience factors, including components of familismo (i.e., familial support and obligations) and
weight stigma. The current proposal directly aligns with the goals of # PAR-21-313 to support new investigators
from groups nationally underrepresented within the field of health sciences (Brooke Kauffman, PI, is a female
new investigator from a disadvantaged background) conducting research aligned with the scientific mission
areas of the National Institute of Diabetes and Digestive and Kidney Diseases. The knowledge and experience
gained from this proposal will be leveraged to guide intervention development and efficacy testing for future
randomized clinical trials. Specifically, this study will enhance understanding and knowledge of precursors to
obesity-related clinical correlates within the Latinx community and provide preliminary data needed to
successfully compete for R01 funding as well as other independent research grants.

Public health relevance
PROJECT NARRATIVE Obesity among the Latinx community in the United States poses a major public health concern. The proposed research aims to study the potential impact of ethnic microaggressions on obesity-related eating (e.g., emotional eating) and physical inactivity (e.g., fears of exercise) behaviors among Latinx individuals with obesity. Such work has the potential to inform future intervention and prevention efforts for this neglected health disparities group.